STATISTICAL AND DATA COORDINATING CENTER FOR CLINICAL RESEARCH ON INFECTIOUS DISEASES

The goal of the Statistical and Data Coordinating Center is to provide comprehensive statistical support, data management and analysis activities for DMID-sponsored clinical research trials. This includes internet-based electronic data collection, data management, data quality control and a specimen tracking system. In addition, the contractor provides consultation on statistics, study design, appropriate control groups, sample size, power calculations, randomization, stratification, and analysis.